DNA damage-induced inflammation and its brain-specific consequences

Abstract
Neurodegenerative diseases such as Alzheimer's and Parkinson's disease represent a diverse group of
conditions. While the loss of brain cells is the most prominent phenotype, each disease also presents with
evidence of a chronic inflammatory process. The proposed work will explore a newly recognized trigger of this
toxic neuroinflammatory process, cytoplasmic DNA (cytoDNA). The cells of the innate immune system, using
cGAS/STING and TLR9, interpret the presence of cytoDNA as an invading viral or bacterial pathogen and
respond vigorously. In aging and neurodegenerative diseases, cellular stresses lead to the release of DNA
fragments from the cell's own mitochondrial or nuclear genome into the cytoplasm, triggering a "sterile"
inflammatory response. Interferon related genes and the NFκB system are mobilized and both cause great
harm if their responses become chronic. Studies of sterile inflammation traditionally focus on the cells of the
innate immune system (e.g., microglia), or accessory cells such as astrocytes. We propose to take a much
broader approach, by separately testing each cell type in the brain for its role in contributing to the chronic
inflammation found in Alzheimer's and Parkinson's. We will track the relative contributions of nuclear and
mitochondrial fragments to the total amount of cytoDNA. As stressors, we will use ATM inhibition, to block DNA
repair, TFAM inhibition to damage mitochondria, as well as more disease-relevant stimuli such as Aβ for
Alzheimer's disease and α-synuclein for Parkinson's disease. We predict that the contributions of mitochondrial
and nuclear cytoDNA fragments will differ in different situations, resulting in unique TLR9 and cGAS/STING
responses that result in a signature secretome that contributes to the diversity of clinical symptoms. To test the
pathological potential of each cytoDNA-stimulated immune response, we will use different stimuli to challenge
cultures of astrocytes, neurons, oligodendrocytes and microglia. We will then collect their conditioned medium
and test it on naïve cultures of the same cell types to isolate the full range of toxic and trophic elements
released from different cells. The transcriptomes of the stimulated cells will be defined by RNAseq; the protein
composition of the secretome will be determined by LC/MS. While our initial studies will be in cultured cells, we
will validate the in vitro findings in vivo using mouse models of three distinct neurodegenerative diseases:
Alzheimer's, Parkinson's and ataxia-telangiectasia. Finally, we propose to develop a multi-pronged strategy to
block the impact of cytoDNA-induced inflammation. We will search for compounds that block the export of
cytoDNA from the nucleus or stimulate its elimination from the cytoplasm. The significance of the findings
derives from the fact that understanding the process of sterile inflammation and how to block it will offer fresh
strategies to improve our approach to many neurodegenerative diseases.

Public health relevance
8. Project Narrative Neurodegenerative diseases such as Alzheimer's are complex disorders affecting many of the brain's cell types with few effective therapeutic strategies known for any of them. Since many of the symptoms of these conditions result from a toxic inflammatory response, we will focus on one newly recognized trigger of this over-reaction: the presence of cytoplasmic DNA fragments originating from the cell's own nuclei and mitochondria. We will determine the details of the triggering mechanism, the composition of the cocktail of inflammatory products and develop screens for new therapeutic compounds against this response.